Environmental acquisition of ST398 Staphylococcus aureus by patients with chronic respiratory disease

Abstract
Staphylococcus aureus is a major human pathogen and a leading bacterial cause of death worldwide. Some S.
aureus lineages, including ST398, commonly infect livestock but are rare in humans. These livestock-
associated bacteria commonly acquire tetracycline resistance from the use of antibiotics for animal production.
Recently, we discovered that over 5% of patients with cystic fibrosis (CF) are infected with ST398 S. aureus,
suggesting that this livestock-associated lineage has jumped into the human population. It is not clear how
these patients developed ST398 infections. The goal of this research project is to determine whether these
ST398 infections persist in people with CF and to identify potential environmental sources such as food or
water are the sources of these infections. We hypothesize that ST398 infections persist for 3 years in half of
patients who become infected. We also hypothesize that ST398 infections are acquired indirectly from
livestock through either contaminated water supply or from the food supply chain. We will test these
hypotheses by prospectively collecting both clinical and environmental isolates of S. aureus and genome
sequencing isolates that are tetracycline resistant, a common marker of this lineage. We will use phylogenetic
and geospatial analysis to rigorously examine the relationship between strains of ST398 that infect patients
with CF and that are found in water collected around the state of Iowa, bioaerosols collected near animal
production facilities, or meat collected from local grocery suppliers.

Public health relevance
Project Narrative (3 lines) Antibiotic resistant bacteria threaten the health of people with chronic health problems. We examine livestock- associated Staphylococcus aureus infections in people with cystic fibrosis with the goal to determine the persistence of infections and whether food, air, or water are environmental sources of these infections.